Project 3: Targeting LSD1 to augment responses to PD-L1 inhibition in small cell lung cancer

Project Summary/Abstract – Project 3
Small cell lung cancer (SCLC) exhibits exceptionally poor prognosis. Addition of immune checkpoint blockade
(ICB) to standard of care improved clinical responses, but few patients achieve durable benefit, in part, because
SCLC tends to suppress expression of antigen presentation machinery. This proposal is focused on using a
targeted therapy, LSD1 demethylase inhibition, to improve responses to immunotherapy in SCLC. SCLC patients
that benefited from ICB exhibited tumors with the following features: 1) suppression of neuroendocrine gene
expression 2) activation of NOTCH, and 3) expression of MHC-I. We showed that LSD1 inhibition suppresses
neuroendocrine features, activates NOTCH, increases MHC-I on tumor cells, and improves response to PD-1
inhibition in vivo, demonstrating potential for LSD1 inhibition to switch immune cold SCLC to become immune
responsive. Mechanisms by which LSD1 inhibition augments immune responses in SCLC, however, remain
poorly defined. Beyond effects on tumor cells, LSD1 inhibition has been shown to directly regulate multiple
immune populations that contribute to anti-tumor immunity. We will develop a deep understanding of the impact
of LSD1 inhibition on tumor cell and immune cell phenotypes, including phenotypes of tumor antigen-specific T
cells. Additionally, there is increasing appreciation of biological heterogeneity in SCLC, in part, driven by
activation of different transcription factors (i.e. ASLC1, NEUROD1 POU2F3 and REST, a repressor of
neuroendocrine state). We need to how SCLC transcriptional subtype impacts responsiveness to LSD1/PD-1
inhibition if we are to better direct this treatment approach to the right population of patients. We will use novel
syngeneic models to understand how LSD1 suppression modulates the TME and sensitivity to PD-1 blockade
across different transcriptional subtypes of SCLC. We will probe the molecular consequences of LSD1/PD1
inhibition on tumor cells and various immune populations using single cell RNA-seq and ATAC-seq. As LSD1
inhibition activates NOTCH and de-represses MHC-I, (phenotypes linked to increased responsiveness to ICB in
SCLC) we will dissect the importance of LSD1 regulation of these pathways for responsiveness to PD-1
blockade. We developed a novel blood-based assay, based on targeted nucleosome profiling of regulatory
regions of ctDNA to correlate SCLC phenotypes with patient responses. We will employ this assay to analyze
longitudinally collected samples from a Phase II clinical trial to be conducted in the maintenance setting in
patients to be randomized to LSD1i/anti-PDL1 vs. anti-PDL1 following initial chemoimmunotherapy. We will
phenotype transcriptional subtype using targeted nucleosome profiling and will call exon mutations across
cancer-mutated genes at trial entry, during treatment and upon relapse. We hypothesize that LSD1i will increase
plasticity, will reduce ASCL1/neuroendocrine SCLC and result in subtype switches away from ASCL1-positive
SCLC. We will also identify biological phenotypes that are associated with strong clinical responses.

Public health relevance
Project Narrative – Project 3 Small cell lung cancer (SCLC) exhibits exceptionally poor prognosis and there is great clinical need to broaden the population that responds well to immune checkpoint blockade (ICB). Our preliminary data support LSD1 inhibition as a mechanism to enhance responses to ICB in SCLC, but we need a better understanding of how LSD1 alters the immune microenvironment and how biologically distinct subsets of SCLC differentially respond to this approach. We propose to study LSD1 inhibition across heterogeneous immune competent SCLC models and to link biological features of SCLC to patient responses towards LSD1 inhibition and anti-PD1 treatment in a clinical trial.